Bio-Behavioral and Community Science Core

PROJECT SUMMARY/ABSTRACT
Bio-Behavioral and Community Science Core (Core J)
We propose to continue the Bio-behavioral and Community Science Core, formerly called the Behavioral and
Social Sciences Core, for the Harvard University Center for AIDS Research (HU CFAR). Since 2014, this Core
has provided consultations and other support to CFAR members for the design of research studies that utilize
state-of-the-art methodologies to develop interventions to limit HIV transmission, and increase serostatus
awareness, engagement in care, and medication adherence, while simultaneously addressing the social and
structural factors that impede achieving these goals. The work of this Core has resulted in 4 HU CFAR
Developmental awards and 25 NIH K- or R-series awards to Early Career Investigators and multiple inter-
CFAR collaborations during the current funding period. The Core has also led several initiatives, including the
establishment of the inter-CFAR Antiretrovirals for Prevention Working Group, co-led with the Emory CFAR,
and active engagement in the trans-CFAR Behavioral and Social Science Research Network. This Core has
also been increasingly focused on community engagement, and the Core leadership is dedicated to engaging
affected communities in the research process and to engaging all key stakeholders about the need for
integration of bio-behavioral, social, and community-based research in HIV treatment, prevention, cure, and
vaccine development. Finally, the increased demand for consultations by this Core indicates a greater
interested in integrating this research. Thus, we propose a Bio-behavioral and Community Science Core with
the following goals: 1) To provide collaborative and consultation services to HU CFAR members on behavioral,
social, structural, and community science aspects of HIV prevention, treatment, and translational research; 2)
To leverage infrastructure from HU CFAR clinical research to facilitate new integrative behavioral/social and
community science studies; 3) To foster sustainable academic-community partnerships through community
engaged research including mentorship of junior investigators, education, and research dissemination.
Specifically, the Core will offer assistance with grant proposals; consultations on methods for qualitative
research, intervention development, quantitative assessment development, mixed-method research, and
community-based participatory research. The Core will continue to add value to the HU CFAR by facilitating
the success of biomedical trials through the integration of behavioral/social sciences early in intervention
design; by catalyzing ideas for combined behavioral/social and biomedical research; and by facilitating strong
academic-community partnerships and obtaining community buy-in, to reduce mistrust and to the hasten the
reach of new technologies into communities.